Diversity Supplement: Enabling advanced endovascular beating-heart procedures through soft robotics

Project Summary/Abstract
In beating heart procedures such as tricuspid annulus reduction, only visual feedback is provided to the
surgeon via imaging and the accuracy in operating surgical tools relies on the quality of the intraoperative
imaging. Hence, there is a need for safe, advanced methods to monitor position and interaction forces of the
robot with the heart tissues to ensure safe and accurate manipulation of delicate heart structures. This proposal
aims at developing an exteroceptive probe that detects pressures applied to the heart structures by the soft robot
developed in the parent grant and contact forces within the heart. Such sensing capabilities will complement
conventional imaging in increasing accuracy in positioning the robot inside the beating heart. It will also allow to
monitor interaction forces and contacts with the heart anatomy. Machine learning (ML) methods will be
investigated to discriminate and decouple the various raw sensory inputs and use them to identify tissues the
probe is in contact with for better localization, safety, and to guide the procedure.
The proposed research has two aims: Aim 3 focuses on sensor design and fabrication of the probe; Aim
4 handles sensor integration with the soft deployable robot, sensory interpretation based on ML, and function
validation through in-vitro and ex-vivo testing. Combined with external and internal imaging, we hypothesize that
the addition of this sensor will increase the accuracy and safety during beating heart surgical procedures. To
monitor pressures applied distally by the robot a soft pressure sensor will be developed. Miniaturized soft contact
sensors will also be integrated on the robot. These sensors will be inspired by the hair-like cilia observed in
biology. Acting similarly to cantilever beams, cilia-like extensions can deflect via fluidic drag forces producing
piezoelectric charges and generating a direction-dependent potential to sense flow rate and direction. We will
develop cilia-inspired sensors around the pressure sensor to monitor contacts experienced by the robot. Taking
advantage of the multiple sensing modalities on the exteroceptive prove, we will investigate the use of ML
application to enhance soft robot awareness and provide tissue recognition and haptic feedback to the surgeon.
These additional components will improve the robot perception of the surroundings. This will lead to 1)
increased accuracy in positioning by integrating the information from onboard sensing with external imaging, 2)
increase safety via monitoring contact and exchanged forces with surrounding heart structures and potentially
paving the way towards integration of haptic feedback, and 3) further increase the accuracy in the control of the
robot by exploiting sensor data to correct model estimation errors.
1

Public health relevance
Project Narrative In beating heart procedures such as tricuspid annulus reduction, only visual feedback is available to the surgeon via imaging and the accuracy in operating surgical tools relies on the quality of the intraoperative imaging. Hence, there is a need for safe, advanced methods to monitor position and interaction forces of the robot with the heart tissues to ensure safe and accurate manipulation of delicate heart structures. This proposal aims at developing soft miniaturized sensors that can be integrated on a soft robot developed in the parent grant to detect pressures applied to the heart structures and contact forces within the heart and use the sensor information to improve robot localization, accuracy, and safety. 1